Unraveling the Impact of Per- and Polyfluoroalkyl Substances on Early Kidney Injury in Adolescents with Obesity and Diabetes

PROJECT SUMMARY / ABSTRACT:
Youth-onset type 2 diabetes (Y-T2D) is a rapidly growing epidemic in the US, with a severe phenotype and
limited modifiable risk factors or effective therapies. Climate change, such as extreme heat, and water
contamination by per- and polyfluoroalkyl substances (PFAS) are emerging risk factors for Y-T2D development
and early diabetic kidney disease. Adolescents with obesity and pre-diabetes may be more susceptible to
PFAS's detrimental effects on β-cell and kidney function due to their developing physiology and increased
vulnerability to environmental stressors, including extreme heat.
In response to NOT-HD-23-006, we propose an administrative supplement to R01 DK129211 for a first-of-its-
kind transdisciplinary study to address knowledge gaps by examining the impact of PFAS exposure and heat
waves on β-cell and kidney function during puberty in adolescents with obesity and pre-diabetes. We aim to
investigate associations between individual PFAS and PFAS mixtures with β-cell and kidney injury during
puberty, and examine whether heat waves modify the relationship between PFAS exposure and β-cell and
kidney injury, hypothesizing that extreme heat intensifies this association. We will quantify PFAS in
participants' plasma and residential water samples and determine heat wave exposure using data from the
Colorado Climate Center and participants' residential history records.
Our second aim is to integrate data on PFAS exposure and heat waves to understand pathways of β-cell and
kidney injury, hypothesizing that PFAS exposure, heat waves, and multi-omic signatures associated with β-cell
toxicity and kidney injury can predict subgroups of youth at risk of T2D onset and progression, and early kidney
disease. We will measure proteomics and metabolomics in plasma and perform Latent Unknown Clustering
Integrating multi-omics Data (LUCID) to integrate environmental factors with multi-omic features.
These findings have the potential to revolutionize our understanding of environmental factors in Y-T2D,
including the role of climate change-related weather events, such as extreme heat exposure, and inform
precision medicine strategies for reducing modifiable PFAS exposure early in life, ultimately preventing β-cell
and kidney damage and alleviating the burden of Y-T2D.

Public health relevance
Project Narrative: This project explores the effects of climate change-induced heat waves, which serve as proxies for droughts, along with per- and polyfluoroalkyl substances (PFAS) exposure, on the development of youth-onset type 2 diabetes and related kidney damage during puberty. Recognizing that climate change-related weather events, such as extreme heat exposure, worsen droughts, threaten water sources, and facilitate PFAS release from melting permafrost, this project aims to inform strategies for reducing exposure and improving public health. Ultimately, this research aims to prevent diabetes and kidney injury in young people, contributing to a healthier, longer life.